Blood flow crosstalk between the endocrine and exocrine pancreas

Project Summary/Abstract
Increasing evidence has demonstrated that disease states of either endocrine or exocrine pancreas aggravate
one another, which implies bi-directional blood flow between islets and exocrine cells. However, this is
inconsistent with the current model of uni-directional blood flow, which is strictly from islets to exocrine tissues,
termed insulo-acinar portal system. Furthermore, exocrine and endocrine compartments of the pancreas have
been studied by different scientific communities, and the diseases of them are treated by physicians in different
medical disciplines, gastroenterologists and endocrinologists, respectively. Notably, it is still unknown why
pancreatic islets, consisting only 1-2% of the pancreas, are embedded in the bulk exocrine tissue as one organ.
We have previously shown that islet microcirculation is integrated with that of surrounding exocrine tissue at its
entirety through intravital in vivo recordings of fluorescent-labeled red blood cell flow as well as in situ imaging
of pancreas vasculature using thick tissue blocks. This new model of the bi-directional blood flow physically links
both compartments. Further anatomical analysis of the spatial relationship between islets and blood vessels has
revealed that the majority of islets had no association with arterioles. Islets with a direct contact with an arteriole
are significantly larger, a pattern that has been observed throughout the examined mammalian species: human,
monkey, pig, rabbit, ferret, and mouse. We hypothesize that the arterioles emerge to feed the bulk exocrine
pancreas regionally with no preferential targeting of individual islets. Vascularizing the pancreas in this way may
allow an entire downstream region of islets and acinar cells to be simultaneously exposed to changes in the
blood levels of nutrients, hormones digestive enzymes and other circulating factors, which could underlie the
pathogenesis of pancreatic diseases including diabetes. In this application, this hypothesis will be tested by
modeling the pancreas blood flow crosstalk using in vivo models (Aim 1). In parallel, the characteristics of the
human pancreatic vascular network will be examined using our unique collection of the whole human pancreata
(currently n>210 spanning the lifetime from 7-days to 85 years of age) and specimens from the Network for
Pancreatic Organ Donors with Diabetes (nPOD) (Aim 2). In this multi-disciplinary proposal, we have assembled
complementary expertise that widely cover all necessarily research fields to accomplish the propose projects:
endocrine and exocrine microcirculation, advanced animal surgery, vascular biology, endocrinology, diabetes,
beta-cell/islet physiology and biology, genetics, pathology, gastroenterology, pancreatitis and pancreatic cancer,
allogeneic and autologous islet transplantation, and immunology.

Public health relevance
Project Narrative The proposed project will precisely map the vessels that supply blood to the two tissues of the pancreas—the exocrine tissue that makes digestive enzymes to breakdown our food and the endocrine tissue that makes insulin to control blood sugar. For many years, those who study and treat patients with pancreatic disorders have been taught that the exocrine and endocrine parts of the pancreas have separate blood supplies that do not mix. However, we have discovered that these two intimately located pancreatic tissues share a common blood supply, and through mapping these blood vessels, we hope to explain how disease in one part of the pancreas often results in failure of the other part.